Origins of Renal Physiology

Project Summary / Abstract
MDI Biological Laboratory seeks NIDDK R25 support for the fourteenth through eighteenth annual offerings of a
one-week course for renal fellows, Origins of Renal Physiology. The course will be held August 2023 through
2027 on the MDI Biological Laboratory campus in Bar Harbor, Maine. The proposed course provides renal fellows
with hands-on research education in fundamental concepts of homeostasis and exposes them to the classical
experiments that form the foundation of renal physiology and nephrology.
Eight course modules are proposed: glomerular filtration and genetics of renal disease, proximal tubule function,
thick ascending limb, salt secretion and balance, collecting duct sodium transport/ENaC, water homeostasis,
renal stone disease, and acid/base homeostasis. Each of the eight modules runs in three consecutive two-day
rotations (Monday-Tuesday, Wednesday-Thursday, and Friday-Saturday), with the first day of each rotation
involving intensive experimental work, and the second day involving analysis and presentation of the work to the
entire course group. Each participant will complete three of the eight planned modules during the three rotations.
A case study-based Responsible Conduct in Research program will be included in the schedule for all
participants.
Origins of Renal Physiology is entirely unique among national renal short courses. The course provides
participants with research tools that give them a deeper understanding of concepts of physiological homeostasis
which is difficult to attain during normal clinical training schedules. The course is open to renal fellows and, since
2010, on a space-available basis, medical residents entering nephrology. Fellows and residents alike benefit
from close interactions with senior investigators in renal physiology who lead the course modules. Residents, in
particular, benefit by working with fellows from different programs and sharing their insights into renal research
and nephrology.
The course is described on the MDI Biological Laboratory website, and in a recent editorial in J. Am. Soc. of
Nephrology (Zeidel et al., JASN 19: 649-50, 2008). Requested funds will cover course tuition and participant
travel; faculty subsistence, stipends, and travel; facility user fees; consultant services; and personnel costs
required to administer the research education program.

Public health relevance
Relevance The course Origins of Renal Physiology is highly relevant to biomedical research and the advancement of human health. The number of annual participants (up to 36; 25 of whom will be funded through this grant) represents approximately 10% of the annual “class” of renal fellows in the United States, permitting the course to have a significant impact on the training of fellows nationally. Course faculty include clinical nephrologists and investigators who guide participants in performing experiments to elucidate kidney function including glomerular filtration, proximal tubule, thick ascending limb, and collecting duct transport, water homeostasis, cellular trafficking of transporter proteins, and the structure-function of transporter proteins such as aquaporins, urea carriers, renal stone disease, ENaC and the Na/K/2Cl cotransporter, and participants will also receive relevant case study-based training in Responsible Conduct in Research.